Stakeholder Engagement and Intervention Support Core

Project Summary/Abstract
Current and future Center for Prevention Research (CPR) investigators will be engaged in epidemiological and
modeling research to better understand patterns and rural factors associated with children's health risk. In a
complementary fashion, developing solutions for these rural health risks will require a richer understanding of
potential intervention pathways and strategies. Child health focused interventions that function in rural settings
will be a key feature of CPR researchers' next step, but such endeavors will require a mixed methods
approach that extends beyond evaluation of existing data. To meet these needs, the Stakeholder Engagement
and Intervention Support (SEIS) Core has been designed with the overall objective of providing CPR
researchers with support to inform thoughtful and testable intervention strategies. In this way the SEIS Core
provides key transitional support as Center investigators pursue R01 funding in the next phase of their
research careers. We will accomplish our overall objective through four Specific Aims. Through Aim 1, we will
establish the SEIS Core, providing CPR investigators support in stakeholder engagement and intervention
design. Intervention support will be provided through primary data collection (Aim 2) and health economics
analyses (Aim 3). Finally, through Aim 4 (stakeholder engagement) we will support CPR investigators in
engagement with regional stakeholders. Following these four aims, the SEIS Core will ensure that CPR
research projects and CPR investigators have the technical and partnership support they need as they pursue
independent research funding in the next step of their research careers and strive to improve children's health
in our rural region.